Exosomal miRNA in neuron to astroglial communication in the CNS

Abstract
Neuron to (astro)glia communication is essential for functional synaptic transmission and physiology in
the CNS. Despite the important modulatory roles of astroglia in synapse function, molecular pathways that
regulate the neuron-astroglia functional unit are largely undefined. Exosomes (50-150 nm in diameter), a major
type of secreted extracellular vesicles (EVs), are derived from intraluminal vesicles (ILVs) in the early endosomal
compartment and are released from cells during endosome maturation. EVs and exosomes secreted from
various CNS cell types have emerged as a novel and important intercellular communication pathway in the CNS.
In particular, miRNAs (miRs) are often found in exosomes to shuttle between cells for intercellular signaling.
Intercellular transfers of miRs have been observed in CNS cells to regulate glutamate transporter function,
promote myelination, and maintain brain vascular integrity. Exosomal signaling has also been implicated in
pathological conditions of the CNS, including neurological injury, neurodegenerative diseases, and glioblastoma.
Despite the strong rigor in prior studies to suggest the importance of the exosomal pathway in CNS cell
communication, these studies are largely based on culture models or human CSF samples, exosome signaling
in situ in the CNS remains essentially unexplored. In addition, fundamentally important cell biology aspects of
this pathway, such as neuronal activity's influence, exosome internalization mechanisms, and downstream
regulation in recipient CNS cells also remain unknown. This is particularly important to address as CNS cell
types are highly distinct from cancer/immune cells where most of exosome knowledge is currently gained and
exosome signaling mechanisms can be very cell-type heterogeneous.
Based on our published study and additional preliminary results, we propose the following aims in this
project: Aim 1: Determine the effect of neuronal activity on the subcellular localization of ILVs and neuronal
exosome secretion; Aim 2: Dissect recognition pathways and entry mechanisms involved in astroglial
internalization of neuronal exosomes; Aim 3: Investigate genetic regulation of neuronal exosomal miR-124 in
astroglia; We have generated a large amount of preliminary data to support our rationales and to demonstrate
feasibility for proposed aims. We will employ mouse genetics, molecular biology, virus injections, various imaging,
and biochemical approaches to complete these aims. Outcomes from this project will present in vivo evidence
to support a previously unrecognized mode of communication from neurons to glia in the CNS. It will also provide
much-needed cell biological knowledge and insights for understanding exosome signaling in neuron to glia
communication, especially about miR-124-3p's non-cell autonomous genetic regulation in astroglia following its
internalization. As altered neuron to (astro)glia communication is clearly implicated in many neurological
diseases, this knowledge and insights can significantly help understand how this pathway is involved in CNS
diseases.

Public health relevance
Narrative Neuron to (astro)glia communication is essential for brain functions and alterations of their communication has been commonly found in neurological diseases. Recently, Exosome signaling has emerged as a novel and important intercellular communication pathway in the CNS. This project will investigate the fundamentally important but currently lacking cell biology of the emerging exosomal miR-mediated neuron to glia communication. Outcome will provide much-needed cell biological knowledge and insights for understanding exosome signaling in neuron to glia communication. This new knowledge can significantly help understand how this pathway is involved in CNS diseases.